Trajectories of social isolation and loneliness among older adults living with HIV who use methamphetamine

Project Summary/Abstract:
This application is being submitted in response to PAR-24-092: Multidisciplinary Studies of HIV/AIDS and
Aging. There is a high prevalence of methamphetamine and other stimulant use among older adults living with
HIV, which places them at high risk for associated adverse outcomes due to co-existing chronic diseases and
functional impairments. This population has also experienced a profound loss of their social networks and is at
risk for social isolation and loneliness. Additionally, older adults who use drugs experience a high level of
stigma related to drug use, treatment, and ageism. All these experiences are also experienced by people living
with HIV and would, therefore, be compounded among older adults with HIV who use drugs. The objective of
this study is to recruit participants living with HIV who currently use methamphetamine (baseline cohort of
n=125) to measure social isolation, loneliness, and intersectional stigma longitudinally and how they may be
related to health outcomes. Aim 1 of this study is to characterize trajectories of social isolation and loneliness
longitudinally at three time points (baseline, 6 months, and 12 months later) along with changes in
methamphetamine use, function, and acute healthcare utilization. Aim 2, through qualitative interviews with a
subset of enrolled participants (n=25), will explore patient perspectives on how social isolation and loneliness
influence HIV care, substance use, recovery, and treatment and elicit perspectives on strategies to address
social connectedness. As an exploratory aim, this study will measure the stigma and discrimination
experienced by this population through validated scales. During qualitative interviews, perspectives regarding
stigma related to methamphetamine use, HIV, ageism, and other potentially related factors will also be
assessed. This research will ultimately inform future interventions to address isolation and disconnection
among older adults with HIV who use methamphetamine. This will have additional public health implications for
the efficacy of improving substance use treatment and health outcomes among older adults living with HIV.

Public health relevance
Project Narrative Older adults with HIV who use stimulants are at heightened risk of being socially isolated, reporting loneliness, and experiencing everyday stigma. As these conditions are interrelated, measuring the lack of social connectedness and its relationship to intersectional stigma with aging is essential for this population, given their possible influence on treatment and health outcomes. The information learned from this research project on HIV/AIDS and aging will inform providers and policymakers across the spectrum of clinical care on improving social connectedness among a growing yet often overlooked population made vulnerable.